Targeting the DNA Damage Response sensor Replication Protein A for first inclass cancer therapy

Abstract
The DNA Damage Response (DDR) is an integrated network of DNA repair and cell signaling
pathways that are critical towards maintaining genomic stability. Targeting the DDR for cancer
therapy exploits two important vulnerabilities of many cancers. This first is that oncogenic
replication stress induces DNA damage and genomic instability resulting in the reliance on DDR
for cancer cell survival. The second is that many cancers harbor genetic defects in DDR and
DNA repair pathway components that force the cancer cells to rewire the DDR and become
reliant on compensatory pathways. This results in the opportunity for synthetic lethal
interactions that can be exploited to specifically target cancer cells. The most successful DDR
targeted therapies inhibit the DNA damage sensor, PARP, a protein that recognizes ssDNA
breaks. With the initial clinical success of PARP inhibitors, development of DDR targeted
therapeutics has become increasingly popular. However, the majority of the current approaches
have targeted protein kinases that are downstream of the DNA damage sensors and the clinical
outcomes with these therapeutics have not met expectations. NERx Biosciences has developed
a novel strategy to realize the full therapeutic promise of the DDR, by intervening upstream of
the DDR kinases and targeting specific DDR sensors. The human single stranded DNA
(ssDNA) binding protein, replication protein A (RPA), is a critical sensor for the DDR and a novel
target for cancer therapy. We have discovered, developed and characterized a novel small
molecule RPA inhibitor (RPAi) NERx-329 that blocks the RPA-DNA interaction and elicits
a state of chemical RPA exhaustion that results in in vivo anticancer activity. Previous
work employed chemical synthesis, in vitro analyses and in vivo xenograft studies to assess
mechanism of action, cellular engagement and therapeutic activity of RPA-targeted agents.
NERx-329 represents the first clinically viable agent to target the DDR pathway by disrupting the
RPA-DNA interaction and holds the potential for significant impact in cancer treatment. The
goal of this direct to Phase 2 application is to accelerate commercial readiness of this novel
therapeutic toward IND approval. This goal will be met through three aims including formulation
for oral delivery of NERx329, assessing pharmacokinetic, potency and safety of NERx 329, and
initiating critical CMC work required for final IND. The key deliverables of each aim will provide a
comprehensive data package that will ultimately position NERx Biosciences to complete final
IND enabling studies for first-in-class and first-in-human trials of novel agents targeting RPA.

Public health relevance
Project Narrative Health Relevance: The research described in this new application has direct relevance to human health in that we are proposing the development of novel therapeutic agents to be used in the treatment of human cancer. We will conduct research exploiting a novel mechanism to impact the DNA damage response to treat human cancer.